Genetic Approaches to Development and Disease

PROJECT SUMMARY
This proposal describes a new PhD training program, Genetic Approaches to Development and Disease
(GADD) at Columbia University Irving Medical Center (CUIMC), which trains young scientists in the use of
modern genetics to address major challenges in biomedical research. There is an essential need for specific
training of PhD students in genetic approaches due to the prevalent use of genetically tractable model organisms,
the evolution of modern genetic techniques, and the complexities of genomic analyses in mammalian systems,
including human patients. The GADD program has been designed to meet this need.
Students in the GADD program receive advanced training in genetic analyses using model organisms,
current genetic and genomic techniques, biostatistics, history of genetics, and the ethics of modern genetics.
The GADD training program functions as a highly selective training program that draws together dynamic, well-
funded faculty and outstanding students from departments and research centers across Columbia University
based on their thematic fit, rigorous research, and mentoring abilities. The training program features a rigorous
curriculum that emphasizes critical thought and development of writing and presentation skills, together with
regular feedback and individualized mentoring of each student. Trainees in our faculty training labs who have
graduated in the last five years show excellent training outcomes, with reasonable time-to-degree (just under 6
years), a high percentage of funding awards (26%) and first-author publications (97%), and successful research,
educational, or research-related careers (94%). A major goal of the GADD program is diversification of the
biomedical workforce through effective recruitment, retention, and support: URM students represent 16% of
current students. The proposed GADD training grant will provide academic, social, and career development
support to all of its students through structured training activities and close monitoring of student progress and
will replace the previous Genetics and Development (G&D) training grant. Overall, the GADD program
represents a premier genetics-focused graduate program that has a long track-record of success in training
leaders in biomedical research and a modern training plan to continue its contributions in the future.

Public health relevance
PROJECT NARRATIVE This proposal describes a new PhD training program, Genetic Approaches to Development and Disease (GADD) at Columbia University Irving Medical Center (CUIMC). The underlying philosophy of this program is that genetic approaches, including forward and reverse genetics as well as genomics and epigenomics, represent effective strategies for dissecting the molecular mechanisms underlying development and disease in vivo. GADD students receive advanced training in genetic analyses using model organisms, current genetic and genomic techniques, biostatistics, history of genetics, and the ethics of modern genetics.